MITOCHONDRIAL REDOX IMAGING AND T1RHO MRI OF BREAST CANCER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Low temperature NADH/Fp (reduced nicotinamide adenine dinucleotide/oxidized flavoproteins) fluorescence imaging or "redox scanning" has been developed to image the in vivo mitochondrial redox states of tissues on the basis of the redox ratios (Fp/NADH or Fp/(NADH+Fp)) and may be useful for clinical diagnosis and treatment of diseases given the central role of mitochondria in cellular metabolism, apoptosis and signaling transductions. Previously we have applied this technique to a panel of human melanoma mouse xenografts with different metastatic potential and identify Fp redox ratio correlates highly significantly with the aggressiveness of these melanomas. We have also shown that T1rho-MRI may differentiate three melanoma mouse xenografts. In this subproject we aim to achieve 1) redox imaging of breast tumor mouse xenografts with different metastatic potentials;2) correlation of 3D redox imaging with 3D T1rho-MRI of breast tumors in mouse xenografts;3) simultaneous imaging of glucose uptake and mitochondrial redox state in tissue;4) identification of imaging biomarkers that can differentiate between aggressive and indolent breast tumors.